Quantitative Systemic Studies of Bacterial Physiology

Project Summary
This research will significantly expand the PI’s unique research program in quantitative bacterial physiology from the
exclusive focus on the model organism Escherichia coli during the past decade to a variety of species across the bacterial
phylogeny, including Vibrio, Pseudomonas, Bacteroides, Mycobacterium, and Bacillus. Transcriptomic, proteomic, and
metabolomic approaches will be applied to these bacterial species for a spectrum of conditions with emphasis on cementing
absolute abundances of the measured quantities as well as the rate of synthesis and turnover. For each species investigated,
we will replicate previous studies for E. coli to derive both coarse-grained phenomenological models as well as establish
relation to molecular regulation. We will also develop methods for inter-species comparisons at the quantitative level. These
studies will not only generate a vast amount of useful quantitative data and models for bacteria of

Public health relevance
Project Narrative (relevance to public health) Understanding the physiological responses of human pathogens such as Vibrio cholera and Pseudomonas aeruginosa to environmental and genetic perturbations and connecting these responses to underlying gene regulatory controls will potentially open up treatment strategies at a systems level. Elucidating adaptive strategies to the inhibitory effects of SCFA on bacterial growth will provide valuable input to the rationale design of probiotics, to endow them with unique fitness advantages in the gut environment so that they can outcompete the undesirable pathogens.